Cell cycle regulation of polarity proteins in proliferating epithelia

PROJECT SUMMARY
Epithelia are polarized layers of adherent cells and the first organized assemblies to emerge during animal
development. As they constitute the scaffolds of most organs, they undergo extensive remodeling and
proliferation throughout the life of the animal. A long-standing question is how proliferating cells maintain their
epithelial organization. Loss of both cell cycle control and epithelial organization result in tissue deformations
and epithelial cancers. Loss of cell polarity, in particular, is one of the most prevalent causes of epithelial
disorganization. Our central hypothesis is that epithelial polarity is under cell cycle control. Work on
proliferative epithelia of the sea anemone Nematostella vectensis has shown that polarity proteins oscillate on
and off the apical domain in concert with the cell cycle. Discovery of similar polarity oscillations in various
epithelia suggest that cell cycle regulation of epithelial polarity is broadly conserved. However, very little is
known about the mechanisms that drive epithelial polarity oscillations and their role in tissue homeostasis. I
propose to use the early developing embryos of Nematostella to investigate how the cell cycle regulates
epithelial polarity. Nematostella embryos form polarized layers within the first few cleavages and maintain this
organization during subsequent synchronous cell divisions. Imaging and molecular biological approaches will
allow us to: [1] Dissect whether and how the cell cycle machinery directly modifies apical polarity proteins, and
[2] Determine how mitotic changes in cytoskeletal organization control apical protein oscillations. The
mechanisms we will uncover are likely to be broadly applicable in other animals and relevant for human
epithelia and their associated diseases.
.

Public health relevance
PROJECT NARRATIVE (Relevance to Public Health) How individual cells come together to form epithelia is critical for the organization and function of a healthy tissue. Addition of new cells through division can compromise the organization of a proliferating tissue and lead to cancer. We are using the tractable sea anemone embryos to study how they undergo cell proliferation while maintaining their epithelial organization.